Development of therapeutic candidates for stimulant use disorder using AI-driven platform for focused drug discovery and accelerated development

PROJECT SUMMARY
Stimulant use disorder (StUD) is emerging as a serious global threat to health, with an exponential
rise in prevalence and overdose deaths. In 2022, 60 million people reported past year use of
stimulants, with 35 million people meeting the criteria for a StUD Currently, there are no FDA-
approved medications for treating StUD, leaving only costly and often ineffective abstinence
support and behavioral therapies, as evidenced by relapse rates as high as 80–90%. This
underscores StUD as a critical unmet medical and social need. VeriSIM Life, a leader in artificial
intelligence (AI)-driven drug discovery, uses its patented BIOiSIM® platform to predict the
pharmacokinetics (PK), pharmacodynamics (PD), and toxicity profiles of potential drug
compounds. This platform employs AI/ML-parameterized whole-body physiologically based PK
modeling, designed to accurately predict a drug's clinical value early in development, thereby
reducing the need for extensive preclinical testing and significantly enhancing return on
investment. During Phase I, we developed, validated, and integrated a specialized PK-PD module
for StUD drug development into our hybrid whole-body iPBPK-PD platform, BIOiSIM. The primary
goal of the STTR Phase II application is to develop novel therapeutic agents against StUD using
an AI-driven platform for new drug synthesis with the following predictions of the PK, PD, and
toxicity profiles. The current Phase II proposal continues the work performed during Phase I when
a comprehensive AI-based PK-PD module for StUD drug development was developed, validated,
and integrated into the hybrid whole-body iPBPK-PD platform BIOiSIM. Aim 1 of the Phase II
study is devoted to the expansion of BIOiSIM’s AI-driven model to enable the prediction of drug
PD parameters characterized by targeting the Ghrelin-1 pathway with the following virtual
synthesis of potent inhibitors with beneficial PK and safety profiles. Aim 2 is specifically focused
on the AI/ML-driven lead optimization of predicted hit molecules to increase their selectivity,
potency, and safety. Aim 3 is dedicated to the AI/ML-driven prediction of the synthesis methods
for the lead compounds, the characterization of their physicochemical properties, and preclinical
testing of the main PK and PD parameters predicted by BIOiSIM®. By harnessing AI technology,
this project aims to significantly expedite the drug discovery and development process, delivering
a drug candidate with a favorable profile ready to proceed to the pre-IND stage by the project's
end.

Public health relevance
PROJECT NARRATIVE Rates of stimulant use and accidental overdose deaths are surging, and currently, there are no FDA-approved medications for treatment. VeriSIM Life will utilize an integral artificial intelligence- enabled platform for drug discovery and development to design and validate novel investigational drugs intended for stimulant use disorder therapy.